Mediator kinase regulation of cardiac transcription

Project Summary/Abstract
Hypertension is a common chronic heart condition resulting in cardiac hypertrophy, dysfunction and heart failure.
Mediator kinase, Cdk8 expression is increased in human and mouse models of heart failure and is sufficient to induce
changes in gene expression networks resulting in cardiac dysfunction. The current proposal has three objectives: 1)
determine the therapeutic potential of small-molecule Cdk8 inhibitors. 2) identify Cdk8 kinase substrates that are
promising, novel therapeutic targets; and 3) determine how Cdk8 mediates cardiac transcriptional responses in vivo (e.g.,
by phosphorylating transcription factors and modifiers) using both the small-molecule Cdk8 inhibitors and Cdk8
conditional cardiac knockout mice. Our central hypothesis is that Cdk8 in cardiomyocytes regulates the transition from a
steady-state to a hypertrophic gene program, driving functional remodeling and cardiac hypertrophy. Our preliminary
data implicate Cdk8 and its substrates as potential therapeutic targets to reduce activation of the hypertrophic gene
network, cardiac hypertrophy, and dysfunction in response to pathological hypertrophic stimuli. The central hypothesis
will be tested via the following specific aims: (1) Confirm that Cdk8 controls the initial cardiac response to pro-
hypertrophic stress [and in the later stage of HF decompensation]. (2) Determine the transcriptional consequences of
Cdk8 expression and activity during hypertrophic stress. (3) Identify Cdk8 targets that differentially regulate the cardiac
hypertrophic response. At the successful completion of the proposed research, the expected outcomes are: an
understanding of the Cdk8 kinase-dependent and kinase-independent mechanisms that serve as a key nodal point in
transcription to drive cardiac pathological gene expression networks and contribute to heart disease, and the
identification of potential new treatment modalities for pathological cardiac hypertrophy and the subsequent disease.
These results will provide a strong basis for further development of therapeutics targeting transcriptional mechanisms
that initiate remodeling of gene networks in response to cardiac stressors, which is expected to have a significant impact
on treating hypertensive cardiac hypertrophy by potentially reducing cardiac transcriptional remodeling. This research
aligns with the NHLBI’s mission to promote the prevention and treatment of heart disease by further defining the
activation of the hypertrophic gene network in models of heart disease.

Public health relevance
Project Narrative This project is relevant to public health because it will contribute to our understanding of the cardiac transcriptional response to stress induced hypertrophy that occurs in both human and rodent models of heart disease. The goal of this project is to determine the function of the Mediator kinase to regulate cardiac gene expression utilizing new genetic and pharmacologic tools combined with NextGen sequencing technology. This research aligns with the NHLBI's mission to promote the prevention and treatment of heart disease by advancing our understanding of the transition from the basal to hypertrophic gene programs through the Mediator kinase and the potential for developing a new therapeutic strategy to treat cardiac dysfunction.